Enhancer RNAs in brain gene regulation and Alzheimer's disease

ABSTRACT
Alzheimer's disease (AD) is the most common form of dementia in elderly population, and is the seventh
leading cause of death in the US. Despite decades of efforts in understanding AD biology and in developing
therapies, effective strategies to cure AD or to alleviate AD symptoms remain limited. AD poses a significant
medical and socioeconomical burden to the world that requires urgent solutions to understand the basis of its
pathogenesis and to develop effective means to prevent cognitive deterioration, or to improve patient lives.
GWAS studies identified many risk genetic variants in the noncoding genome regions, particularly in
enhancers, suggesting key roles of enhancer malfunction and gene deregulation in AD pathogenesis.
Epigenetic studies of human AD brains also revealed significant changes such as histone acetylation at
enhancers. Better knowledge of gene deregulation and enhancer malfunction is critical to better understand
AD pathology and to identify new therapeutic targets. The recent findings that active enhancers often generate
noncoding enhancer RNAs (eRNAs) have provided a new perspective to interpret enhancer malfunction in AD.
This proposal aims to explore a unique direction by characterizing the molecular mechanisms underlying eRNA
functions in brain and AD. Our overall hypothesis is that enhancers were aberrantly active in AD, resulting in
deregulated eRNAs to assemble ribonucleoprotein complexes (RNPs) to organize a nuclear RNA compartment
that can impact gene expression networks in brain cells. We have assembled a strong investigator team to test
this hypothesis with three specific aims. First, we plan to identify deregulated eRNAs from both human
samples and iPSC derived neuron and microglia cells, and identify functions of specific eRNAs in AD
associated gene regulation. Second, we will study mechanisms of eRNAs' functions in depth, by using a robust
RNA capture method that we have developed to systematically identify neuronal and microglia eRNA:protein
interactomes. We will examine the mechanisms of eRNA-binding proteins (eRBPs) in regulating AD associated
enhancer and gene transcription, and in impacting the three-dimensional genome architecture. Third, based on
our recent findings of a critical role of RNA m6A methylation on eRNAs in enhancer activation and signal
induced gene transcription, we will examine eRNA methylome in human brain samples and iPSC derived
neuron/microglia in response to AD-associated signaling. This aim will uncover new knowledge to understand
how chemical modifications of chromatin associated RNAs may mechanistically impact gene transcription to
contribute to AD. Together, the expected results from this proposal will not only provide mechanistic insights
into brain gene regulation and noncoding RNA functions in AD, but also can offer new therapeutic targets and
strategies to intervene this devastating disease.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease (AD) is a significant health problem in the United States that poses great medical and socioeconomical burdens to this country, the solving of which demands new molecular insights into its mechanisms of development. Here we employ human brain samples, advanced cell models and epigenomic techniques to explore a new area of enhancer-derived RNAs in human brain gene deregulation and AD pathology. This study will lead to molecular characterization of unexplored ncRNA players in AD that can provide novel targets and pathways for AD diagnosis and therapeutic intervention.